Discovery of host genetic elements affecting response to immune checkpoint inhibitors

PROJECT SUMMARY
Abrogating immune checkpoint control has proven to be a powerful therapeutic strategy against cancer with
documented long-term remissions in refractory metastatic disease. However, only a subset of patients (10-40%)
have meaningful responses. While intrinsic tumor factors play a role in predicting immune checkpoint inhibitor
(ICI) outcomes, germline variations in host immune genes are also likely to have a significant impact given their
importance in defining immune response and autoimmunity. That both the tumor and the host genomes vary
makes the identification of germline factors modifying ICI response highly challenging. We have solved this
problem by devising a mouse experimental platform that “fixes” the genomic configuration of the tumor as a
transplantable cell line (MC38) while varying germline host genetics, thus permitting the unbiased mapping of
quantitative trait loci (QTL) for anti-tumor response after anti-PD1 (aPD1) therapeutics. By crossing Collaborative
Cross (CC) multiparent recombinant inbred lines with the C57BL/6 strain, the resultant F1s have genetic
variability but will accept the MC38 transplant. In preliminary data, we show that host genetics accounts for 42%
of the variation in aPD1 response (heritability, H2) and have mapped aPD1 response to four QTLs on mouse
(m)Chr 5, 9, 15, and 17 enriched for immune genes. By selective intercrosses between responder and non-
responder CC lines, we found significant epistatic interactions between chromosomes 5 and 17 and between 15
and 17. We devised a cross-species tumor microenvironment (CST) algorithm that reduced the ~1,500 genes in
the QTLs to 48 top candidate genes that could predict ICI response in human trials, outperforming current
theranostic biomarkers. Based on these data, we propose to expand and refine the QTL map for ICI response
in the MC38 model with a focus on defining the genetic mechanisms for the epistatic interactions (Aim 1). In Aim
2, we will challenge the three top candidate genes, Csf2rb and Il2rb (mChr15) and Il10ra (mChr9), with available
recombinant cytokines and blocking antibodies towards predicted changes in aPD1 response. These
perturbations will allow us to further map the genetic network that establishes the optimal tumor immune
microenvironment. We will then expand our studies by mapping the QTLs associated in the murine mammary
cancer model AT3 (Aim 3). We anticipate that new QTLs for response will be uncovered. Finally, in Aim 4, we
will use the CCF1 tumors to optimize an innovative in vitro micro-organosphere (MOS) platform that encapsulates
cells of the tumor microenvironment in a permeable microcapsule amenable to pharmacological intervention and
cellular interrogation. Once optimized, we will test a panel of ICI drugs alone and in combination on both murine
and human tumors. The success of the proposed work will not only identify potential new biomarkers and new
targets for augmenting clinical ICI response, but also will establish a validated platform for the discovery of host
genes involved in the response to any immune checkpoint inhibitor.

Public health relevance
PROJECT NARRATIVE Despite the remarkable clinical success of immune checkpoint inhibitors (ICIs) in treating previously refractory cancers, the majority of patients still do not have meaningful responses, likely due to tumor-intrinsic and to host- specific factors such as the genetic make-up of the patient. We have developed powerful genetic platforms based on advanced genetically diverse mouse models, computational algorithms, and patient-derived micro- organosphere (MOS) technology to map genes in both mice and humans that modify host response to an ICI. Our enhanced understanding of host genetic mechanisms governing ICI response will be important to devising predictive biomarkers and, importantly, novel therapeutics to enhance ICI effectiveness; thus, we now propose to expand on our recent discoveries to precisely define the genetic network controlling host response to ICIs, and to test emerging ICI and ICI combinations in our integrated genetic diversity/MOS system.